Large scale single-cell gene rearrangement detection with a microfluidic device

Acute myeloid leukemia (AML) contributes to 32% of all adult leukemia and
remains one of the most clinically devastating cancers. Currently, AML diagnosis, risk
stratification and treatment selection are mainly based on cytogenetic abnormalities,
which suffers from low sensitivity and low resolution. To overcome this technical hurdle,
we propose to use single-cell RNAseq with microfluidic devices to generate a molecular
version of AML cytogenetic profile including all mRNA abnormalities from a large
number of leukemia cells, a technique we have named S-CytoSeq. This molecular S-
CytoSeq profiling provides fusion genes (FG) and alternative splicing (AS) profiles at
single-cell resolution and will have a significant clinical impact on AML treatment. The
ultimate translational goal is to replace conventional cytogenetics with S-CytoSeq.

Public health relevance
Acute myeloid leukemia (AML) contributes to 32% of all adult leukemia and remains one of the most clinically devastating cancers. Currently, AML diagnosis, risk stratification and treatment selection are mainly based on cytogenetic abnormalities, which suffers from low sensitivity and low resolution. To overcome this technical hurdle, we propose to use single-cell RNAseq with microfluidic devices to generate a molecular version of cytogenetic profile including all mRNA abnormalities from a large number of cells.